Tendon loading profiles that promote healing in Achilles tendinopathy

PROJECT SUMMARY
Mid-substance Achilles tendinopathy is a painful, debilitating, and chronic tendon pathology. Rehabilitation
exercises are the first treatment option for patients, but clinical studies have reported 20-60% of patients
continue to experience pain and symptoms 5-years later. Even when patients experience symptom relief, only
one-quarter of these patients fully recover muscle-tendon function. Current clinical guidelines recommend
patients perform heel-rise exercises to eccentrically load the pathologic tendon and promote healing. However,
Achilles tendon loading during daily-living often exceeds these structured rehabilitation loads, and the
biomechanical properties of pathologic tendon varies amongst patients. Identifying patient subgroups based on
similarities in tendon loading and biomechanics is a critical next step towards improving patient outcomes and
tendon healing. Our long-term goal is to develop personalized rehabilitation protocols that maximize tendon
recovery following acute and chronic Achilles tendon injuries. The overall objective of this study is to determine
similarities in tendon loading and biomechanics in patients with mid-substance Achilles tendinopathy and how
these similarities affect tendon healing, pain, and functional outcomes. This study leverages innovative
techniques to 1) continuously monitor Achilles tendon loading during rehabilitation and daily-living and 2)
quantify tendon status using ultrasound stress-imaging. Aim 1 will identify groups of patients with Achilles
tendinopathy based on loading patterns and stress-imaging profiles. Aim 2 will determine if tendon healing and
outcomes change over time. Aim 3 will explore the impact of sex on tendon healing and outcomes. This study
will be the first to identify Achilles tendon loading profiles that are associated with tendon healing and
outcomes based on patient-specific factors including tendon biomechanical properties and sex. By measuring
circulating levels of sex hormones, this study will determine if specific levels of estrogen and progesterone –
which can be modified using hormonal contraceptive pills – impact tendon health. Finally, with the recent shift
towards telemedicine, this study will remotely monitor Achilles tendon loading, which has the potential to
expand clinical care beyond patient visits to the clinic.

Public health relevance
PROJECT NARRATIVE Achilles tendinopathy is a painful condition that does not fully resolve in 20-60% of patients following conservative treatment. In this study, we will determine rehabilitation loading profiles and ultrasound imaging biomarkers that explain tendon healing and functional outcomes in patients. We will also measure circulating levels of sex hormones to determine how variations in sex hormones impact tendon healing and outcomes.